Deciphering the underlying mechanisms of craniofacial spliceosomopathies

PROJECT ABSTRACT
Nager syndrome (OMIM#154400) is a rare craniofacial and limb disorder characterized by midface retrusion,
micrognathia, absent thumbs, and radial hypoplasia. This disorder results from mutations in the SF3B4
(splicing factor 3b, subunit 4) gene, which encodes SAP49, a protein that is a component of the spliceosome.
The spliceosome is a complex of RNA and proteins that function together to remove introns and join exons
from transcribed pre-mRNA. While the spliceosome is present and functions in all cells of the body, many
spliceosomopathies – including Nager syndrome – are often cell/tissue-specific in their pathology. In Nager
syndrome patients it is the neural crest (NC)-derived craniofacial skeletal structures that are affected. The
mechanisms underlying Nager syndrome pathology, as well as its tissue-specificity, are poorly understood.
Interestingly, other craniofacial spliceosomopathies, such as craniofacial microsomia (SF3B2), mandibulofacial
dysostosis Guion-Almeida type (EFTUD2), Burn-McKeown syndrome (TXNL4A), and Verheij syndrome
(PUF60) share similar clinical features with Nager syndrome, however it is unclear if they are caused by the
same underlying mechanisms. In this application, I will combine use of a Xenopus tropicalis sf3b4 mutant line
and Nager syndrome patient-derived induced pluripotent stem cells (iPSCs) to tease apart the mechanisms
underlying Nager syndrome. This combination of in vivo and in vitro approaches will provide novel insights into
the mechanisms driving craniofacial defects in the context of Nager syndrome, which can then be translated to
other craniofacial spliceosomopathies to determine if they share a common root cause. The proposed
experiments will test the hypothesis that SF3B4 has NC-specific targets and/or binding partners, and upon
mutation these interactions are disrupted or lost, leading to abnormal NC development and subsequent Nager
syndrome-associated craniofacial defects. I have crafted three specific aims to test this possibility. Specific Aim
1: Using preliminary data from RNA-seq analyses performed on a Xenopus tropicalis sf3b4 mutant line, I
propose to identify the biological pathways disrupted in Nager syndrome by testing candidate genes via gain-
and loss-of-function experiments in Xenopus tropicalis. Specific Aim 2: In collaboration with the Columbia Stem
Cell Core, I propose to generate and characterize a Nager syndrome patient-derived iPSC line, and use this
line to characterize NC in the context of Nager syndrome. Specific Aim 3: In the R00 phase of the application, I
plan to use the knowledge and experience from modeling Nager syndrome and develop in vivo and in vitro
models of other craniofacial spliceosomopathies in order to determine their root cause. Altogether these
studies will provide novel insights into the mechanisms underlying Nager syndrome craniofacial defects, which
can be used to inform work on other craniofacial spliceosomopathies, establishing a unique view on
understanding craniofacial development and disorders.

Public health relevance
PROJECT NARRATIVE Nager syndrome (OMIM#154400) is a developmental disorder characterized by hypoplasia of the facial bones and a variety of limb defects. Mutations in the SF3B4 gene, which encodes a protein involved in the maturation of pre-mRNA, is a major cause for Nager syndrome. In this application I propose to gain novel insights into the mechanisms underlying Nager syndrome craniofacial defects through in vivo and in vitro modeling of the disease, and carry that knowledge over to the modeling of other craniofacial disorders to determine if there is a common root cause.